NRG Oncology - Statistical and Data Management Center

Abstract
The mission of the NRG Oncology Statistics and Data Management Center (SDMC) is to
provide all necessary expertise and personnel for the design, conduct and analysis of clinical
trials and associated research for NRG Oncology, a member group of the NCI National Clinical
Trials Network (NCTN) program. The 2019-2024 cycle represents the second period of the
NCTN program, which succeeded the NCI Cancer Cooperative Group program and of which
NRG Oncology was formed by the unification of three of the Cooperative Groups. NRG
Oncology has unique expertise in gender-specific malignancies (breast, gynecologic, and
prostate cancer), as well as a major presence in several other cancer types (head & neck, lung,
brain, upper GI) where multimodality therapy has a critical role. In the first cycle of the NCTN
(2014-2019), the NRG SDMC and partner NRG Operations Center personnel expended
significant effort in successfully transforming into a truly united and highly functioning group.
Concurrently, the group made significant strides in advancing cancer treatment, ancillary care,
and cancer biologic knowledge. During the first cycle, the group initiated 32 trials and obtained
final approval on an additional 14 trials for development, while maintaining follow-up to primary
and secondary endpoint reporting on over 80 additional trials that were active at the inception of
NRG Oncology. Publications from the group through the initial 5 years number over 300,
including 39 methodology articles by SDMC statisticians.
To carry out its mission, the NRG Oncology SDMC will collaborate closely with NRG
Oncology Operations leadership and trial investigators to design and conduct the highest quality
clinical trials that will yield definitive conclusions. The SDMC will provide continuous trial
conduct oversight through all stages from concept inception through protocol development, trial
activation, trial monitoring, and dissemination of findings. Through its quality assurance
program, the SDMC will provide quality control monitoring across the lifecycle of trials. The
SDMC will continue to apply, or develop as needed, innovative statistical designs in all phases
of clinical trials, using integrated developmental trial phases where advantageous, and
incorporating biomarker-based information into trial designs and analysis plans. The SDMC will
continue to Implement state-of-the-art data management and information technology systems to
assure secure high-quality data collection, maintenance, and curation for additional discovery
and data sharing with the larger research community.

Public health relevance
Project Narrative While outcomes have been improved for many cancers, there remains a substantial need to develop and rigorously evaluate more effective therapies while also improving the quality of life and well-being for cancer patients. NRG Oncology, a member of the National Clinical Trials Network (NCTN), addresses this challenge, and the NRG Oncology Statistics and Data Management Center (SDMC) is an integral component critical to ensuring that NRG Oncology clinical trials are properly designed, implemented, conducted, analyzed, and disseminated. This application seeks resources for the NRG Oncology SDMC to support the NRG Oncology and NCTN research agenda for the 2019-2024 program period.